Pancreatic Cancer-Associated Fibroblasts: Function, Detection, and Regulation

PROJECT SUMMARY/ABSTRACT
Pancreatic Cancer (PC) survival rates are very low and even lower for patients from low socioeconomic
backgrounds/circumstances (SES), often living in geographic locations with limited access to care. One
explanation for this disparity could be chronic stress. Several researchers, including our Collaborative
Investigator, have shown that Black individuals and those living in neighborhoods with low SES endure sustained
exposure to stressful circumstances (e.g. systemic racism, lack of resources), which impact mental health (e.g.
anxiety, fear) and augment PC. Neighborhood SES (nSES) hence serve as a macro-environmental indicator of
chronic stress, independent of a patient’s SES and mental health. Low nSES, can for example prevent cancer
cell death and promote its aggressiveness. If the biologic basis of PC health disparities is to be elucidated,
studies proposing to understand how, for example, nSES impacts PC are needed. The parent grant focuses on
studying the non-cancerous cells and natural scaffold units of the pancreas in PC. Of note, the specific molecules
studied are implicated in chronic stress. In fact, some chronic stress features, such as glutamate excess, are
simulated by the non-cancerous units of the pancreas during PC. We reported that pro-tumorigenic activation
of these units are indicative of unfavorable PC patient outcomes. Interestingly the same units also are implicated
in synapse stability in brain and in the generation of small membranous vesicles that are produced by these units
and can be detected in blood. Building on this, our parent grant proposes to: i) reveal how the natural scaffold of
these units regulates pro tumoral unit functions; ii) assess whether detection of the unique unit-generated
membranous vesicles inform on the pancreatic tumor-promoting vs. tumor-suppressing, status of PC patient’s
organ; and iii) question if the molecules relevant for driving pro-tumoral function of the units can be targeted.
Here we plan to expand this scope by forging a multidisciplinary partnership with a disparity research expert Dr.
Shannon Lynch in the form of 3 specific new aims:
Aim 1: Measure biomarkers (high Glu, & others) and macro-environmental measures of chronic stress (nSES;
racial segregation) to determine if high levels of environmental stress correlate with biologic stress.
Aim 2: Evaluate the correlation between chronic stress measures (biomarkers, macro-environmental
measures) and pro-tumoral circulating biomarkers in vesicles informing on local stress-like microenvironments.
Aim 3: Determine if microenvironment-indicative biomarkers are associated with PC patient survival time,
alone and after adjustment for comprehensive chronic stress measures and race/ethnicity in multivariable
regression models.

Public health relevance
PROJECT NARRATIVE This study uniquely couples chronic stress endured by individuals residing within underserved geographic locations (neighborhoods) with biological, tumor-promoting, markers generated by the non-cancer pancreatic cells during pancreatic cancer. The study, hence, aims to inform on key biologic basis of pancreatic cancer health disparities, an understudied, but NCI high priority area.